Developmental Funds

The cancer center utilizes developmental funds to recruit new faculty to areas of Inquiry that may not have all of the desirable disciplines represented, to stimulate pilot studies (on occasion directed towards topics that the Senior Leadership considers to be important or fertile), and to create prototype shared resources. Thus, Developmental Funds are used to improve the scope and depth of cancer-related research at UC Davis and through its integrated cancer program with the Lawrence Livermore National Laboratory, the scope and depth of collaborative scientific undertakings.

Public health relevance
Cancer research is not static and new opportunities or challenges arise, and there Is a continuing need as well to cultive new scientific leadership; through Developmental Funds, the center is able to address changes In cancer research, new areas that promise new therapies, and build a complement of highly productive scientists across a broad spectrum of cancer-related research interests.